In-depth Understanding of HIV Risk Behavior among Men Who Have Sex With Men in Sub-Saharan Africa: Secondary Analysis of HPTN 075 Data

The aim of this project is to use the rich data collected for the HIV Prevention Trials Network (HPTN) 075 study
to expand our understanding of the sexual behavior and HIV risk practices of men who have sex with men (MSM)
in sub-Saharan Africa (SSA). HPTN 075 was a vanguard study with the primary aim to assess the feasibility of
recruiting and retaining 400 men who have sex with men (MSM) in sub-Saharan Africa (SSA) in preparation for
further HIV prevention studies. This aim was successfully addressed in a multinational, prospective biobehavioral
cohort with five study visits over a one-year follow-up period. Each study visit included behavioral and clinical
assessments. The study was conducted from 2015 to 2017 in four sites: Blantyre in Malawi, Kisumu in Kenya,
and Cape Town and Soweto in South Africa. HPTN 075 showed an alarmingly high HIV prevalence and
incidence among MSM in SSA: 30% of all MSM screened for participation tested HIV positive and an overall
incidence was found of 7.0/100 person-years (PY) (95% CI: 4.3, 10.6). Engagement in condomless anal
intercourse was the strongest determinant of incidence. The HPTN 075 data set is exceptionally rich: the
involvement of four study sites in three countries; detailed assessments of sexual behavior, including on the
dyad-level; and the longitudinal design with extensive screening data and five study visits. This rich data will be
used to advance our understanding of factors that drive HIV transmission and that need to be addressed to end
the HIV epidemic in SSA among MSM and, because of the high prevalence of MSM who also have sex with
women, among the general population. The following questions will be answered: (1) Does engagement in
condomless anal sex change over the duration of the study due to study-related HIV-risk counseling and
improved access to condoms, and which characteristics of the individual (e.g., age, HIV risk perception), the
sexual partnership (e.g., age concordance, relationship status), and the sexual encounter (e.g., substance use,
place of interaction) are independently associated with condom use? (2) What are the features of sexual
interactions that MSM have with women? How do their sexual interactions with men compare to the same-sex
interactions of MSM who exclusively have sex with men? (3) What are the characteristics of MSM who engage
in transactional sex and how do they differ from men who do not? How are transactional sex interactions different
from sexual interactions that are not transactional, and in what way does receiving or providing benefits in
exchange for sex affect these differences? (4) What patterns of substance use can be distinguished among MSM
in SSA? Are these patterns predictive of HIV incidence and what is the mediating role of condomless receptive
or insertive anal sex? (5) Are there differences between countries in sexual behaviors corresponding to the
national differences in the legal status and social acceptance of same-sex sexuality? Findings from this study
will inform the development of an implementation science study (R01) addressing the needs of MSM in SSA.

Public health relevance
Findings from this secondary data analysis will inform the development of an implementation science R01 study that, as a follow-up to HPTN 075, will design and test the implementation of multi-level strategies to promote evidence-based biomedical HIV prevention tools. The obtained knowledge will allow us to tailor intervention components to the specific needs of subgroups (e.g., MSMW, substance users), resulting in a more nuanced and potentially more effective approach.